Project 1

Temporomandibular disorders (TMDs) encompass a group of complex conditions predominantly
affecting women, characterized by diverse causes and clinical presentations that significantly
reduce quality of life through limitations in jaw function, head and neck pain, sleep disturbances,
and psychological distress, thereby impacting daily activities, work productivity, and social
interactions. Evidence from clinical, behavioral, and biological studies indicates that TMDs
involve multisystem disruptions, including overlaps with chronic pain conditions, heightened
psychological distress, poor sleep quality, biomechanical joint and muscle alterations,
autonomic nervous system dysregulation, differential DNA methylation patterns, altered
inflammatory markers, and brain changes associated with pain processing and therapeutic
responses. Despite these insights, the clinical variability of TMDs hinders effective prognosis
and individualized interventions, necessitating comprehensive phenotyping to identify
reproducible subtypes and facilitate targeted therapies. Our project aims to establish a national,
interdisciplinary, patient-centered research infrastructure through CREATE, a collaborative
network leveraging resources and expertise across multiple institutions to conduct a large-scale,
multi-site clinical study. This initiative includes characterizing diverse TMD cohorts through
clinical and behavioral measures (Aim 1), identifying biomarkers linked to distinct phenotypes
(Aim 2), tracking longitudinal changes to predict trajectories and outcomes (Aim 3), and
developing clinically informed preclinical models to establish causal mechanisms and optimize
diagnostics and treatments (Aim 4). The study will utilize advanced data analytics, including
traditional and AI-driven approaches, to analyze data collected over two years, incorporating
biomarkers, ecological momentary assessments, and wearable device metrics to refine
phenotypic classifications. Access to existing datasets such as OPPERA, BACPAC, and RE-
JOIN will enable validation and replication of findings, supporting the development of targeted
prevention and intervention strategies. Ultimately, this collaborative effort, integrated with the
Bioinformatics and Data Science Core and aligned with stakeholder needs, seeks to transform
TMD care by enhancing diagnostics, improving treatment precision, and reducing the burden of
these complex disorders, offering substantial benefits for patients and advancing the field of
TMD research and clinical practice.